NeuroSync: a data-driven, music-based augmented reality neurorehabilitation platform of games & puzzles to stimulate neuroplasticity and prolong functional independence in Alzheimer's Disease patients

Abstract
Alzheimer’s Disease (AD) is a neurodegenerative disease characterized by adverse neuropathological
changes that compromise neural connectivity and the body’s ability to repair brain tissue, obstruct elimination of
neural toxins, and inhibit delivery of vital nutrients to the brain. The culmination of this damage is a fatal brain
atrophy that destroys the brain’s ability to communicate with the body, robbing its victims of their memories,
independence, and identity. Currently, there are no drugs that cure AD, and contemporary medical treatments
are largely ineffective for delaying the disease. However, recent insights in AD pathogenesis suggest therapies
that enhance plasticity in neural circuits will be key to future treatments that slow and/or reverse its progression.
As a result, there is rising momentum for evidence-based methods that stimulate neuroplasticity, coupled with
treatment approaches that leverage this neurobiological phenomenon to support healthy longevity in AD patients.
Notably, Neurologic Music Therapy (NMT) offers one such approach by using the neuroscience of music to
design tailored therapeutic interventions that stimulate neuroplasticity and target measurable improvements in
functional independence and quality of life, and shows promise of revolutionizing next-generation AD treatments.
Informed by these considerations, Outlier is developing NeuroSync: a data-driven, NMT-based augmented
reality (AR) neurorehabilitation platform which will improve the ability of clinicians, therapists, and caregivers to
offer affordable, personalized neurological care to AD patients. NeuroSync features a structured program of
immersive, evidence-informed neurorehabilitative games, puzzles, and exercises that use analytics captured on
the user’s performance and interactions with musical movement to adapt the interventions in response to the
user’s evolving medical needs and abilities. This innovative system is rationally designed to combine nostalgia,
music creation, movement, bioinformatics, and machine learning (ML) to allow AD patients to instantly harness
the therapeutic benefits of creating music from body motion, on day 1. NeuroSync delivers a groundbreaking
neurorehabilitative platform that bridges the gap between therapies typically administered by trained practitioners
in clinical settings with those that can be safely used at-home, as users “play” their way to better health.
In Phase I, Outlier successfully demonstrated proof-of-concept for NeuroSync with feasibility testing of 1st gen
prototypes of its patent pending “smart instrument” The Human Element (THE) and 6 neurorehabilitative
interventions. In phase II, we will continue this work by developing a 2nd gen version of THE, expanding its
musicality with ML and broadening computer vision training for more inclusive activity recognition and intuitive
mappings. We will then optimize the Phase I interventions and develop 5 new adaptive interventions with greater
therapeutic range that support a broader array of user musical preferences, motion capabilities, and healthy
longevity goals. Finally, we will develop a web and desktop app for the 2nd gen NeuroSync, with usability testing
to optimize performance prior to a 4-month pilot study to gather evidence of its potential efficacy with AD patients.

Public health relevance
Project Narrative Recent insights into the pathogenesis of Alzheimer’s Disease (AD) suggest therapies that enhance neuroplasticity will play a key role in future treatment approaches that slow and/or reverse its progression . Towards this end, Outlier Technology, LLC is developing NeuroSync: a novel, Neurologic Music Therapy (NMT)- based neurorehabilitation platform that offers a structured program of adaptive, personalized evidence-based interventions that evoke a unique combination of nostalgia, active music creation, movement, pattern recognition, and cognitive challenges to stimulate neuroplasticity and stabilize and/or improve metrics of neurological health and quality of life. This technology will 1) make personalized music-based neurological care more accessible to AD patient-caregiver dyads and 2) offer analytics and decision support tools to providers; to bridge the gap between therapies traditionally administered in clinical settings with those that can be safely used at-home, offering a groundbreaking and affordable new approach that empowers users to “play” their way to better health.